NUTRITIONAL AND GASTROINTESTINAL EFFECTS OF A LIQUID FORMULA DIET IN AIDS

This study is determining the effects of different liquid formula diets when given as the only source of food on diarrhea and nutritional status in people with AIDS.